Accurate, Needle-Free, MRI-based Detection of Ischemic Heart Disease without Contrast Agents

PROJECT SUMMARY
Ischemic heart disease (IHD) is the leading cause of death in the United States. It emanates from narrowing of
coronary arteries (CAD) and/or development of microvascular dysfunction culminating in myocardial ischemia
– a condition where the oxygen demand of the myocardium is far in excess of the available supply. IHD
accounts for more than 1 in 3 deaths and >1 million hospitalizations each year in the US. The extent and
severity of myocardial ischemia has been shown to provide incremental prognostic value over standard clinical
variables across the spectrum of presentation of patients with IHD. Long-established (SPECT or PET) and
more recently established (e.g., first pass-perfusion MRI) methods are routinely used to gather this information.
In spite of their capabilities, these methods have key limitations – they expose the patients to either ionizing
radiation or exogenous contrast agents, which carry risks to the patients. This is particularly a critical problem
in at least half a million patients with end-stage renal disease (ESRD) in the US. In ESRD patients, annual
ischemia testing is needed since the risk of cardiovascular mortality is > 10-fold greater than in the general
population. Hence there is an unmet and growing need for safe and reliable assessment of myocardial
ischemia in all patients, and is most pressing in ESRD patients, whose prevalence in the US is on the rise.
Blood-Oxygen-Level-Dependent (BOLD) Cardiac MRI (CMR) is a potential alternative to standard clinical
methods since it is free of ionizing radiation and exogenous contrast media. It also has the capability to provide
physiological insight into the disease based on measurements of impaired oxygen supply, and not from
surrogate metrics (wall motion, ECG changes, or contrast kinetics). Over the past two decades, the technical
capabilities of BOLD CMR have led to clinical testing. However, limitations in reliability (sensitivity, specificity
and accuracy) remain a major impediment for widespread clinical use of BOLD CMR. To overcome the
reliability limitations of BOLD CMR, in a previous R01 funding (2013 to 2017), we hypothesized that repeat
stimulations of the heart, analogous to brain activation studies using BOLD MRI (brain fMRI), could improve
the reliability of BOLD CMR. Subsequently, we went onto demonstrate that (i) a targeted change in arterial
partial pressure of CO2 (PaCO2) can be a potent non-invasive vasoactive stimulus; and a (ii) high-resolution,
whole heart BOLD CMR at 3T with repeat PaCO2 stimulation of the heart, when combined with a statistical
framework, can reliably detect BOLD signal changes in large, healthy, animals. To successfully translate the
promising impact of this BOLD CMR approach into the clinical arena, further advances and validation will be
required. This proposal aims to continue the successful advancement of this BOLD CMR approach towards
clinical feasibility so that it can enable a truly noninvasive and cost-effective ischemia testing that is free of
ionizing radiation, exogenous contrast agents, intravenous pharmacological agents or even needles. Thus, this
proposal is a critical step towards advancing the care of a large segment of IHD patients in the US.

Public health relevance
PROJECT NARRATIVE Cardiac stress tests are crucial for managing ischemic heart disease (IHD), which affects >16 million Americans, but current stress tests expose patients suspected of IHD to ionizing radiation or exogenous contrast agents. The potential risk from stress tests are most pressing in the management of end-stage renal disease patients (>0.5 million in the US), who require annual stress testing as they are at high risk of developing and dying from IHD. This proposal aims to address this limitation by developing a clinically viable cardiac MRI approach which could enable a truly noninvasive and cost effective ischemia testing that is free of ionizing radiation, exogenous contrast agents, intravenous pharmacological agents or even needles.